How Tetraspanins Regulate Sepsis

Vascular inflammatory responses determine the onset, progression, and consequence of
sepsis. Tetraspanin CD82 proteins are expressed in endothelial cells (ECs) and leukocytes. Our
recent study revealed that CD82 facilitates vascular inflammatory responses during sepsis. We
demonstrated that, to facilitate inflammation, endothelial CD82 promotes lipopolysaccharide (LPS)-
induced vascular leakage, leukocyte recruitment, and endothelial release of cytokines, leading to
marked increase in mortality of animal with sepsis. How CD82 promotes the inflammatory events in
blood vessels during sepsis is unclear.
The goal of this study is to identify the mechanisms by which CD82 facilitates vascular
inflammatory responses in sepsis at the molecular, cellular, and organism levels. We hypothesize
that, CD82 facilitates the vesicular trafficking of inflammation-related molecules such as VE-
cadherin, E-selectin, and cytokines, to promote inflammatory responses in sepsis and therefore
exacerbate sepsis.
In this project, we will first determine how CD82 inhibits vascular stability in sepsis by assessing
the regulatory roles of CD82 in i) inflammation-induced disruption of EC-EC contacts/junctions and
ii) recovery of endothelial barriers from the disrupted EC-EC contacts/junctions. Secondly, we will
determine the mechanism by which CD82 promotes vascular recruitment of leukocytes during
sepsis by assessing CD82 effects on the i) levels, ii) activities, and iii) turnover of inflammation-
related cell adhesion proteins in ECs and leukocytes during sepsis. Finally, we will determine how
CD82 inhibits cytokine secretion in sepsis by i) assessing in vivo and in vitro effects of CD82 on
cytokine secretomes, ii) revealing CD82 roles in exosome formation and exocytosis, and iii)
identifying the Rab GTPase(s) crucial for CD82-regulated exocytosis.
This project will fill important knowledge gaps for the regulatory mechanisms of vascular
inflammatory events in response to septic injury, leading to systemic vascular dysfunction, at the
molecular, cellular, and organism levels. This project will also establish CD82 as a novel
therapeutic target for ameliorating systemic vascular dysfunction during sepsis and improving the
survival of sepsis patients.

Public health relevance
Project Narrative Systemic dysfunction of blood vessels is the major cause for the death of patients with sepsis and other severe inflammations, and thereby understanding how vessels respond to inflammations is crucial for successfully treating systemic inflammatory diseases such as sepsis. Herein, we will determine how a tetraspanin protein promotes the inflammatory responses of blood vessels at molecular, cellular, and animal levels, and this project will also provide insight into the general mechanisms that govern systemic and severe inflammatory diseases such as sepsis.